Services to Operate the National Oral Health Information Center (NOHIC)

The purpose of this contract is to continue operation of the National Oral Health Information Center (NOHIC), including but not limited to provision of a wide variety of management, technical, logistical, and administrative services. NOHIC currently serves as a resource for practitioners, educators, patients, and the public seeking information about oral, dental and craniofacial diseases, disorders and conditions; treatments; prevention strategies; research; and special care.